Srsf3-mediated alternative RNA splicing in craniofacial development

Project Summary
Craniofacial development is a complex morphogenetic process, disruptions in which result in highly
prevalent human birth defects. Signaling through the platelet-derived growth factor receptor alpha (PDGFRa)
plays a critical role in this process in humans and mice. Pdgfra mutant mouse models display midline facial
clefting phenotypes. Phosphatidylinositol 3-kinase (PI3K) is the primary effector of PDGFRa signaling during
skeletal development in the mouse, leading to activation of the kinase Akt. A previous phosphoproteomic
screen identified Akt phosphorylation targets downstream of PI3K-mediated PDGFRa signaling in primary
mouse embryonic palatal mesenchyme (MEPM) cells, revealing a significant enrichment for proteins that
regulate alternative RNA splicing (AS), such as the RNA-binding protein (RBP) Srsf3. Ablation of Srsf3 in the
mouse neural crest lineage leads to facial clefting due to defective cranial neural crest cell proliferation and
survival. Further, Srsf3 regulates the AS of transcripts encoding protein kinases in the mouse facial process
mesenchyme to regulate PDGFRa-dependent intracellular signaling. These findings have shifted the paradigm
on how RTKs regulate gene expression and have identified post-translational modification of RBPs involved in
AS downstream of PDGFRa signaling as a critical mechanism contributing to craniofacial development. The
goal of this proposal is to determine the molecular mechanisms by which Srsf3 activity is regulated to generate
protein isoforms necessary for midface development. First, to identify proteins that differentially interact with
Srsf3 depending on its phosphorylation in response to PDGFRa signaling, Srsf3-interacting proteins will be
immunoprecipitated from MEPM cells with or without PDGF-AA treatment and identified by mass spectrometry.
Separately, Srsf3-RNA interactions will be purified and sequenced in response to PDGF-AA ligand stimulation
through enhanced crosslinking and immunoprecipitation analysis to identify which transcripts are directly
bound by Srsf3 and to determine if the extent of RNA binding and/or sequence specificity of these interactions
changes upon Srsf3 phosphorylation. Second, craniofacial phenotypes will be assessed in Srsf3
phosphomutant knock-in embryos and RNA-seq analysis will be performed to identify AS targets of Srsf3 that
depend on Srsf3 phosphorylation. The relationship between PDGFRa and Srsf3 will be dissected using this
allele in genetic epistasis experiments. Finally, craniofacial phenotypes will be assessed in Srsf3 ectoderm-
specific conditional knock-out embryos. The AS targets of Srsf3 will be identified in the facial mesenchyme and
overlying ectoderm at the onset of craniofacial phenotypes through RNA-seq analysis. The splicing programs
regulated by Srsf3 in each compartment will be correlated with biological processes active during craniofacial
development. This project will delineate a complete pathway from PDGFRa at the cell surface to Srsf3 and its
target transcripts in the nucleus. These studies will provide significant insight into what are likely broadly-
applicable mechanisms underlying gene expression regulation during mammalian craniofacial development.

Public health relevance
Project Narrative Dysregulation of alternative RNA splicing has been shown to cause numerous diseases, ranging from muscular dystrophies to neurological disorders, dilated cardiomyopathy, retinitis pigmentosa and cancer. Mutations in core spliceosome components cause spliceosomopathies in humans, which are characterized in part by craniofacial defects, and have been speculated to disrupt alternative RNA splicing in neural crest cells in particular. By identifying the molecular mechanisms by which the activity of the splicing factor Srsf3 is regulated, as well as its alternative RNA splicing targets in the facial mesenchyme and overlying ectoderm, the research strategy outlined in this proposal has the potential to provide significant insight into the mechanisms underlying gene expression regulation during mammalian craniofacial development and new therapeutic directions for the treatment of human craniofacial birth defects.